Causal mechanisms in adolescent arterial stiffness

Aortic stiffness measured in adolescence or adulthood determines current hypertension, predicts future
incidence of hypertension, and future cardiovascular disease (CVD) events International hypertension guidelines
list severe aortic stiffness as grounds to intensify anti-hypertensive pharmacotherapy. Mechanisms of arterial
stiffness beyond aging and obesity warrant further elucidation. In our preliminary data from adolescents attending
weight-loss summer camps arterial stiffness improvement was not associated with weight change but was with
change in circulating carnitine. Carnitine influences fatty acid oxidation and carbohydrate metabolism. Carnitine
could therefore link to arterial stiffness through insulin resistance which in turn affects cellular tone, vascular
fibrosis, modification of lipids or glucose metabolism, and/or advanced glycation end products. This proposal
leverages 2 instrumental variable study designs to infer a causal relation between carnitine and arterial stiffness.
First, in 166 adolescents at risk of arterial stiffening due to high serum TGs, we will conduct a mechanistic, double
blinded, RCT for the effect of 6 months of oral carnitine supplementation (CS+, n=83) versus placebo (CS-,
n=83) on aortic stiffness measured as carotid femoral pulse wave velocity (CFPWV); serum fatty acid oxidation
biomarkers by metabolomics analysis; insulin resistance as homeostatic model assessment of insulin resistance
(HOMA-IR); and trigylcerides (TG). Aim 1 is to compare CS+ versus CS- on change in arterial stiffness and
monitor adverse events. The hypothesis CS+ is associated with lower arterial stiffening, and CS+ effect is not
modified by sex or race/ethnicity. Aim 2 is to compare the effect of CS+ versus CS- on fatty acid metabolism,
insulin resistance, and lipids. The hypothesis is that CS+ alters long chain fatty acid beta oxidation, measured
as lower long chain acylcarnitines, which in turn improves (HOMA-IR), and in turn decreases TG levels. This
causal chain will be disentangled for direct versus indirect effects on CFWPV change. Second, naturally
randomly assorted carnitine SNPs noted above will be used to characterize the relationship of carnitine to arterial
stiffness and stratify the effectiveness of CS+.Aim 3a is to obtain the direct effect of carnitine on arterial stiffness
using Mendelian randomization of SNPs associated with serum carnitine as instrumental variables with the
hypothesis these variant SNPs are associated with lower arterial stiffness, supporting a causal inference. Aim
3b is to identify effect modification of CS+ vs CS- on arterial stiffness by examining if a carnitine genetic risk
score will modify the effect of CS+ on change in arterial stiffness. This proposal with 2 instrumental variable
projects would evaluate a causal role for carnitine in arterial stiffness at a point when the life course trajectory to
hypertension can be modified. The study will also investigate the role of carnitine in insulin resistance and
dyslipidemia at this same age, which may serve as grounds for future therapeutic clinical trials. Discovering
genetically mediated causes of arterial stiffness or other outcomes may facilitate targeting of future therapies on
susceptible youth before atherosclerotic changes are irreversible.

Public health relevance
PROJECT NARRATIVE Hardening of the blood vessels, called arterial stiffness, is a risk factor for future heart disease and its causes are unclear. The proposed study will 1) randomly assign adolescents at high risk of stiffening blood vessels to take a protein supplement called carnitine and study its effects on arterial stiffening and 2) study carnitine related genes for their effect on arterial stiffening. The study will definitively establish a role for carnitine action as a cause of stiffening blood vessels and signal a way to treat or prevent stiffening.